Administrative Core

This Program Project involves the participation of researchers from 5 different Institutions each of them located in a distinct city and state (University of Texas Medical Branch in Galveston, TX; University of Kentucky in Lexington, KY; National Animal Disease Center in Ames, IO, Hematech Inc in Sioux Falls, SD; and Case Western Reserve University in Cleveland, OH). To reach the aims of this project it is essential to maintain an effective integration and communication of the different participants in this initiative. The main goal of the Administrative Core is to integrate Projects and Cores and take care of all administrative aspects needed for the smooth operation of the Program.